Executive Control and Adolescent Weight Trajectories

Project Summary
Deficits in executive control (EC), a critical set of cognitive abilities for directing attention and behavior, have
been proposed as an important and modifiable contributor to obesity risk; however, the role of such deficits in
the development of clinical weight problems is not well-understood. Existing research on EC and obesity lacks
critical developmental and environmental context, precluding an understanding of when and how poor EC
impacts obesity risk and limiting the ability to design developmentally-sensitive and targeted interventions
addressing EC to prevent and treat clinical weight problems. Given that preschool and adolescence are both
critical periods in the development of EC, and that adolescence is a time of increasing independence and
obesity risk, a longitudinal study spanning preschool and adolescence is needed to explicate the impact of EC
on weight trajectories within a rich developmental context. Further, the obesogenic environment that surrounds
an adolescent is critical to understanding the EC-obesity relationship, yet studies exploring the role of EC in
this broader environmental context are lacking. The long-term goal is to inform interventions targeting EC as a
novel and modifiable risk factor for obesity at critical points in development. The objective of the proposed
research is to explicate the impact of EC on weight trajectories and obesity-relevant behaviors in adolescence,
in the context of a longitudinal study leveraging earlier EC data from the critical period of preschool. The
proposed study also seeks to understand this relationship in the context of environmental risk by examining
how the obesogenic environment interacts with EC to affect weight trajectories. The central hypothesis is that
poor EC, at various points in development, will contribute to subsequent obesity risk and obesogenic behaviors
in adolescence, and that this effect will be particularly pronounced for youth living in more obesogenic
environments. The rationale is that a longitudinal study of EC and weight trajectories, within developmental and
environmental contexts, would richly inform the timing and targets of potential interventions focusing on EC to
prevent and treat obesity. The specific aims are to: (1) Determine the impact of EC development on weight
trajectories in a longitudinal study spanning preschool to adolescence; (2) Determine the impact of EC
development on adolescent obesity-relevant behaviors in this longitudinal study; and (3) Explore the role of the
obesogenic environment as a moderator of the relationship between EC development and adolescent weight
trajectories/obesogenic behaviors. The project is innovative in its unique leveraging of existing EC data from
the sample and its combination of cognitive neuroscience and systems science to explore brain-environment
interactions and their influence on health. The significance of this research is that it will yield an unprecedented
understanding of the EC-obesity relationship within developmental and environmental contexts. These insights
will inform the timing and targets of novel obesity interventions targeting both individual EC at key points in
development and environmental factors that affect the demand for EC to enact healthy behaviors.

Public health relevance
Project Narrative The public health relevance of the proposed research is in explicating how individual differences in a modifiable set of critical cognitive abilities – developing executive control (EC) – impact risk for obesity and obesogenic behaviors within developmental and environmental context. By understanding when and under what environmental conditions EC deficits contribute to obesity risk, the proposed study will directly inform the timing and targets of interventions to bolster EC in the context of obesity prevention and treatment. Thus, the proposed research is relevant to NIH’s strategic focus on understanding modifiable factors that contribute to obesity risk to inform interventions to promote healthy weight.